Peroxiredoxin 1 in Pancreatic Beta-cells

Research Project 4 - Abstract
Pancreatic -cells are responsible for synthesis and secretion of insulin in response to a glucose challenge.
Diabetes mellitus occurs when an individual is unable to produce sufficient insulin to meet the needs of their
body, causing chronic hyperglycemia. This can occur either by -cell loss or by -cell dysfunction. The formation
of reactive oxygen (ROS), such as hydrogen peroxide, has been implicated in the demise of -cells during
diabetes development because of its ability to damage DNA, deplete cellular energy stores, and ultimately lead
to cell death. Furthermore, it has been suggested that -cells are vulnerable to this oxidative damage due to
reportedly low levels of antioxidants. However, this view is at odds with several fundamental characteristics of
-cells. First, ROS are produced by the pathway (mitochondrial oxidative metabolism) responsible for glucose
sensing and glucose-stimulated insulin secretion, and their production is directly proportional to the blood
glucose concentration. Further, -cells are essential for survival of the organism as the only cell type capable of
expressing and secreting insulin. Since they are essential, yet have a limited capacity to replicate, it would be
evolutionarily advantageous for -cells to possess mechanisms to protect themselves from ROS. In agreement
with this view, our previous studies suggest that -cells maintain a robust antioxidant system relying on
peroxiredoxins and thioredoxins. Indeed, acute inhibition or depletion of peroxiredoxin 1 (Prx1), encoded by the
gene Prdx1, in insulinoma cells or isolated rodent islets significantly increases their sensitivity to hydrogen
peroxide, leading us to our central hypothesis: peroxiredoxin 1 is necessary for pancreatic β-cell survival and
function. Here, we propose the following aims: (1) to test the hypothesis that Prx1 is necessary for β-cells to
protect themselves against ROS in vivo, and (2) to test the hypothesis that Prx1 is necessary for normal β-cell
function. The proposed studies will help us better understand the potential dual role of peroxiredoxin 1 not only
in protecting -cells from ROS but also in promoting normal -cell function. It is our hope that the pathways that
are illuminated in these studies will provide novel targets for therapeutic intervention designed to preserve
functional β-cell mass and attenuate or prevent diabetes development.